Toxicology studies to evaluatedevelopmental, neurobehavioal and immunologic Func

The purpose of this contract is to conduct studies which will help the National Toxicology Program (NTP) in the toxicologic characterization associated with developmental exposre to a variety of chemicals on the Developmental, Neurobehavioral and Immunologic Function. The following studies have been initiated: (1)A definitive study to evaluate Neurobehavioral and immunologic function in Sprague Dawley rats exposed to 3,3',4,4'-tetrachloroazobenzene (2) Study to evaluate preimplantation loss following administation of 3,3',4,4'-tetrachloroazobenzene in Sprague Dawley rats.